Epigenetics, DNA repair and Genomics (EDGe) Training Program in Cancer

Here we propose a new Epigenetics, DNA repair and Genomics (EDGe) Training Program in Cancer to support 4 pre-doctoral students per year. EDGe will take advantage of a thematic interest in the fields of DNA repair and epigenomics and the intersection of these fields in the context of cancer to provide opportunities for interdisciplinary training and interactions among students and dedicated training faculty. The UTHealth SA's Integrated Biomedical Sciences (IBMS) graduate program is interdisciplinary; many students specialize in cancer-related disciplines, including Cancer Biology, Biochemical Mechanisms in Medicine and Cell Biology, and Genetics and Molecular Medicine. Within these three disciplines in particular, there is a strong interest in both DNA repair and epigenetic control of transcription programs as it relates to cancer biology, though we will not limit to these three disciplines. Another focus is the critically important interface of DNA repair, transcription regulation, and chromatin organization to elucidate the basis of cancer development and identify potential therapeutic strategies. This T32 training program takes advantage of faculty expertise (25+ experienced mentors), a multi-disciplinary leadership structure, and the availability of a curriculum infrastructure of relevant topics that can provide cross-disciplinary training in cancer biology for our next generation of cancer biologists. The highly interactive faculty mentors bring training expertise in critical aspects of DNA repair and epigenetics, from biochemical structure/function to cell biology, bioinformatics, and translational approaches. The first two years of the IBMS graduate program include completing two years of coursework, both general IBMS courses and core discipline-specific courses. Students will be appointed to the proposed T32 for 2 years, after passing their qualifying exam and following rigorous competitive evaluation and interview. As part of this EDGe Training Program, we will require trainees to acquire cross-disciplinary training to strengthen their understanding of cancer biology, DNA repair, and epigenetics, including cancer biology core courses and bioinformatics. Trainees will also be required to take an institutional course on responsible conduct of research, be involved in trainee-organized event planning, and participate in additional enrichment activities, such as the Texas-wide Genome Instability Group seminar series. They will also be expected to participate in T32-specific meetings comprising research-in-progress presentations and to attend the Mays Cancer Center's annual retreat. As one of four NCI-designated cancer centers in Texas and the only one focused on South Texas, the MCC seeks to recruit and retain students from our unique catchment area. With an overall goal of enhancing the trainees' outcomes by using competitive criteria for selection and augmenting mentoring. EDGe will be evaluated annually by an External Advisory Committee and quarterly Executive Committee meetings. This T32 proposal has broad institutional support, reflected by financial commitments from the Graduate School, the Long School of Medicine, the Mays Center and the Office of the Vice President for Research.

Public health relevance
A steady stream of new researchers is necessary to continue the fight against cancer, one of the primary causes of death in the U.S. To achieve this goal, it is critical that we train the next generation of scientists in state-of-the-art cancer research; this is a key aspect of this proposed training program. The goal of this Epigenetic, DNA repair and Genomics (EDGe) Training Program in Cancer is to train 4 Ph.D. students per year in multidisciplinary cancer research building on our institutional faculty's strength in DNA repair and epigenetics - key areas that impact cancer development and treatment.